Drug combination nanoparticles for advanced treatment of metastatic TNBC

Project Description
Triple negative breast cancer (TNBC) is the most challenging subtype to treat among all breast cancer cases
due to lack of cell surface receptors. Patients with metastatic TNBC have median overall survival of only 13.3
months with treatment. Newly approved immune checkpoint inhibitors such as PD-1 antibody only extend the
survival by 2-4 months when used with chemotherapy, and the efficacy highly relies on expression of targets
such as PD-L1 in tumors. Despite new treatment options, metastatic TNBC is predominantly treated by highly
potent chemotherapy, with combination therapy being advantageous over single agents regarding response rate
and overall survival. However, the drugs in combination chemotherapy have distinct physicochemical properties
that hinders formulation into single dosage; their distinct pharmacokinetic behavior hinders the in vivo synergism.
Furthermore, these drugs are non-specific to cancer cells and often show systemic toxicity. Our long-term goal
is to develop advanced and well-characterized drug delivery approaches to improve treatment outcomes of drugs
and drug combinations. In this project, we propose a dual-drug loaded dual-peptide ligand incorporated drug
combination nanoparticle (DCNP) approach for targeting and inhibition of metastatic TNBC. The lipid-based
DCNP leverage on effective gemcitabine and paclitaxel combination in clinic to deliver both drugs in prolonged
and synchronized manner. Through incorporation of two peptide ligands that targets TNBC cells (through ICAM-
1) and tumor vasculature (through endoglin), the DCNP could target both primary tumor and metastasis for
enhanced chemotherapy. Furthermore, both drugs are reported to upregulate PD-L1 and reduce population of
myeloid derived suppressor cells (MDSCs) in the tumor. These effects can sensitize TNBC cells for PD-1/PD-L1
therapy. The DCNPs that synchronize and co-deliver both drugs may further augment such effects thus generate
improved chemoimmuno therapeutic outcomes. The objectives of this project are to validate the concepts of
improved targeting and chemotherapy of metastatic TNBC with a dual-targeting DCNP approach and enhanced
combination therapy with immune checkpoint inhibitors. In Aim 1, we will prepare ligands-incorporated DCNPs
with high drug loading, proper size, and good stability, and test their cellular binding and efficacy, and effects on
cancer cell expression of PD-L1. In Aim 2, we will validate enhanced in vivo targeting efficiency with the dual-
ligand strategy and correlate it with expression levels of receptors and evaluate inhibition of primary tumor and
metastasis with monitoring of survival. In Aim 3, we will assess the upregulation of PD-L1 and reduction of
MDSCs by the DCNPs and carry out a pilot survival study with a chemoimmuno combination regimen. If
successful, this targeted drug combination strategy could substantially improve the treatment of metastatic TNBC.
Through tuning composition and targeting ligands, this highly translatable nanoformulation technology can be
potentially used for existing and future drug combinations to treat various metastatic cancers.

Public health relevance
Project Narrative Metastatic triple negative breast cancer is a devastating disease where the best chemotherapeutics, immunotherapeutic and their combinations still yield limited life-extension outcomes. Leveraging on the benefits of chemo/immuno therapeutics and an innovative targeted drug combination nanoparticle strategy, this project aims to co-deliver drugs into metastatic cancer cells for enhanced chemotherapy and immune checkpoint inhibitor therapy.